Interpretable machine learning methods for the analysis of Alzheimers disease genetics

Alzheimer’s disease (AD) is the most common cause of dementia among people over the age of 65, affecting
an estimated 5.5 million Americans. It is now well-established that drug trials based on evidence with a genetic
basis are more likely to succeed. However, known genetic markers identified by current genome-wide
association studies (GWAS) only explain a small fraction of heritability for late-onset AD (8-17% out of 56-79%).
Among them, the causal variants and their effect are only known for a minority of cases. To date, over 400 million
genetic variants in the human genome have been sequenced. The causal variants tend to be sparsely spread
across the genome with multiplex nonlinear effects on AD. This is far more than the current analytical and
experimental approaches can analyze with adequate power.
Machine learning (ML) approaches, including deep learning/neural networks, can efficiently learn linear and
nonlinear relationships and have been used successfully in many scientific problems. Meanwhile, recent
advances in genome sequencing provide an exciting opportunity to apply ML methods to genetic data analysis
of AD. However, for application of ML to genetic studies, it is generally difficult to quantify how changes to the
genetic variants influence the disease outcome. Although explainable artificial intelligence (XAI) methods have
been developed to improve the interpretability of ML and to quantify the relative importance of input features (e.g.
genetic variants), there is little to no development for rigorous control of the error rate of selected features - a
property critical for reproducible science but less studied in existing XAI methods.
The objective of this proposal is to develop rigorous feature selection in ML methods and pair them with causal
inference to discover causal genetic variants of AD that could lead to novel targets for the development of new
AD therapies. At the Stanford Alzheimer's Disease Research Center, we have curated a database that combines
large-scale genetic and multi-omics datasets. The proposed methods will be applied to genetic data from a total
of roughly 500,000 samples harmonized across ADGC, ADSP and UKBB. The findings will be validated using
real functional experiments, single-cell RNAseq data and proteomics data. We expect that the application of the
proposed methods will significantly improve our understanding of the multiplex nature of AD and, critically,
provide a credible set of well-defined, novel targets for the development of genomic-driven therapies.

Public health relevance
Project Narrative The proposed research is relevant to public health because understanding sequence variations in the human genome will provide insights into Alzheimer’s disease (AD) and assist in the development of emerging AD therapies. The proposed methods will identify causal variants of AD and translate the discoveries into mechanistic insights and drug targets for the development of new AD therapies to improve human health. Therefore, this proposal is relevant to the part of NIH’s mission that pertains to fostering fundamental creative discoveries, innovative research strategies, and their applications as a basis for ultimately protecting and improving health.